PYRUVATE RECYCLING IN REGULATION HEPATIC GLUCOSE PRODUCTION

Several articles reporting data obtained at the Facility by Dr. Bruce Berkowitz have been published and are included in this report. A new faculty member, Dr. Nadir Alikacem, has been recruited and has begun work on this project. (Service 15) REPORT PERIOD: (09/01/97-08/31/98)